Discovery of viral and host pathways that protect HIV-infected macrophages from NK cell ADCC

PROJECT SUMMARY
Characterization of HIV reservoirs and the immunoevasion mechanisms permitting persistence has largely
focused on CD4+ T cells. Yet macrophages represent a physiologically relevant reservoir, with characteristics
that may uniquely contribute to viral persistence. They can bud and store virus within virus-containing
compartments, which largely exclude neutralizing antibodies, and resist the cytopathic effects of infection.
Furthermore, en masse, macrophages vs CD4+ T cells are more resistant to killing by CTL and NK cells. Our
published work shows that macrophages resist both NK cell innate cytotoxicity and antibody-dependent cellular
cytotoxicity (ADCC), but the mechanisms of this evasion are unknown. As passive transfer of broadly neutralizing
antibodies has shown much promise in the cART-free treatment of infection, understanding how macrophages
respond to HIV antibodies and how they might succumb to ADCC would aid the design of inclusive HIV cure
strategies. Interestingly, while HIV antibody-enhanced NK cell signaling/activation and release of
perforin/granzymes towards infected macrophages vs CD4+ T cells is significantly lower, HIV-specific CAR T
cells activate in response to both infected cell types equally well. The overall objective of this research project
is to determine the mechanisms of how infected macrophages antagonize NK cell signaling that induces ADCC.
Given that NK cells signal in response to multiple target cell surface ligands, which are likely different on CD4+
T cells vs macrophages, the central hypothesis of this project is that infected macrophages present an inhibitory
signal that is not on CD4+ T cells, which counteracts NK cell ADCC. Specific Aim #1 will characterize the effects
of HIV accessory proteins on ADCC-triggered NK cell signaling towards CD4+ T cells vs macrophages. Previous
studies suggest that NK ligands can affect ADCC. Since the HIV accessory proteins Nef and Vpu differentially
affect CD4+ T cells and macrophages, they may also elicit differential regulation of NK cell ligands in these cell
types, leading to differences in ADCC-triggered NK cell signaling. Using HIV with genetically ablated accessory
proteins, we propose to assess how each protein regulates the NK cell ligand repertoire and ADCC-triggered
NK cell signaling. While these viral proteins may explain the ADCC differences towards the targets, Specific
Aim #2 will define how Fc𝛾 receptor (Fc𝛾R) binding to HIV antibody, which also binds to the surface Env on
macrophages (in cis) affects ADCC-triggered NK cell signaling (in trans). Fc𝛾R expression on targets cells, which
inhibits ADCC towards transplanted cell therapeutics, may be the dominant factor that protects macrophages.
We propose to use CRISPR KO of Fc𝛾Rs in macrophages and lentiviral overexpression of Fc𝛾Rs in CD4+ T
cells to determine the effects of Fc𝛾Rs on ADCC towards infected cells and uninfected targets that overexpress
HIV Env. Together, these studies will provide insight into the mechanisms of macrophage resistance to ADCC,
which may help in the design of more effective and inclusive HIV cure strategies, such as blocking accessory
protein function with small molecules or design of bNAbs that limit macrophage Fc𝛾R reactivity.

Public health relevance
PROJECT NARRATIVE While CD4+ T cells are the dominant HIV reservoir, tissue-resident macrophages also contribute to viral persistence, thus a more thorough understanding of macrophage reservoirs and the cell-specific differences that may uniquely contribute to viral persistence is of significant interest. As our previous work shows that infected macrophages are less susceptible than CD4+ T cells to NK cell HIV antibody-mediated killing, this proposal seeks to understand both the viral-mediated effects and the cell-intrinsic characteristics of macrophages versus CD4+ T cells that contribute to this discrepancy in killing. Characterizing these mechanisms will provide insight for the design of more inclusive cure strategies to better target HIV macrophage reservoirs, such as HIV antibodies to boost NK cell detection and killing of macrophages, and small molecules to target HIV proteins that prevent NK cell killing.